Mechanisms that coordinate cell size and mitotic entry

A wide variety of cell types delay cell cycle transitions until they reach a critical size threshold, but
the mechanisms that measure size and transmit this information to the core cell cycle machinery
are largely unknown. Fission yeast cells divide at a specific surface area due to signaling by large,
multi-protein structures called “nodes” at the cortex. Nodes contain conserved cell cycle
regulators including the protein kinases Cdr2, Cdr1, and Wee1, which function in a linear,
genetically defined pathway to regulate mitotic entry. Recently, we discovered that nodes also
contain the conserved GTPase Arf6 and found that Arf6 promotes mitotic entry through the Cdr2-
Cdr1-Wee1 pathway. We do not know the mechanisms of assembly or signal transduction within
nodes. We will address key open questions using powerful genetic, biochemical, and quantitative
imaging approaches. Mutations that abolish node signaling cause cells to divide at a specific
volume, as opposed to surface area. Based on several lines of evidence, we hypothesize that
regulated accumulation of Cdc25 in the cell nucleus represents the volume sensor. We will test
the model that cell size control emerges from different pathways, each monitoring distinct aspects
of cell geometry. We will focus on the fundamental process of cell cycle regulation, but our work
has broad implications for spatial control of signal transduction because higher-order clusters and
node-like structures are emerging as critical sites of signal transduction throughout cell biology.
The specific aims of this grant are to: (1) define the molecular mechanism of Cdr2 node assembly
and function, (2) determine how Arf6 GTPase regulates Cdr2 nodes and cell size at division, and
(3) test the model that Cdc25 and Cdr2 pathways monitor distinct aspects of cell geometry.
Successful completion of these goals will advance scientific knowledge by identifying how defined
signaling pathways respond to different aspects of cell growth. Moreover, the signaling
mechanisms that we uncover will provide insights for how size controls the activity of other
biological systems.

Public health relevance
Defects in the mitotic entry control system can lead to genomic instability, a hallmark of cancer. We will use the model organism fission yeast to define of the upstream signals that govern this cell cycle transition. These findings will be important to understand the cellular mechanisms that prevent untimely and inappropriate cell divisions, which contribute to human diseases such as cancer.